Retrosplenial Down state assembly facilitates memory consolidation during slow-wave sleep

PROJECT SUMMARY/ABSTRACT
System consolidation of memory involves a cortical-hippocampal-cortical loop of information
processing; however, it remains unclear how this process is initiated. Converging evidence suggests
that slow-wave sleep (SWS) plays an essential role in memory consolidation. During SWS, various
cortical regions exhibit a prominent delta oscillation (0.5–6 Hz) that enables coordinated interactions
across the brain via synchrony. This delta wave exhibits a cyclic Up and Down pattern: the Up state
corresponds to high cortical activity, whereas the Down state coincides with near-total cortical silence.
Therefore, each Down state functions as a reset to position key cortical regions for information
exchange during the subsequent Up state. One key unanswered question is whether there is a unique
group of cortical neurons that primarily drive SWS Down-to-Up transitions for memory consolidation.
Utilizing large-scale in vivo recording and advanced analysis techniques, we recently discovered that a
distinct subpopulation (~20%) of retrosplenial cortex (RSC) layer-5 neurons initiates firing during SWS
Down states. We termed these neurons RSC Down-state assembly (DSA) neurons. Preliminary results
revealed that RSC DSA neurons exhibit robust synchrony at SWS Down-to-Up transitions, which
precedes the activity of other RSC neurons. Moreover, RSC DSA neurons increased their activity
between pre- and post-training sleep after a new learning experience, indicating their role in memory
consolidation. The central objective of this proposal is to test our hypothesis that RSC layer-5 DSA
neurons play a key role in initiating SWS Up states to drive memory consolidation. Supported by
considerable preliminary data, we propose to pursue this objective through the following two specific
aims. Aim 1 investigates the neural dynamics of RSC layer-5 neurons in memory consolidation. Aim 2
investigates the connectivity and causal role of RSC DSA neurons in memory consolidation. Results
from this study will advance our understanding of RSC neuronal activity dynamics and the delta
oscillation generation mechanisms underlying memory consolidation. This could provide insight into the
improvement of memory and interventions in memory disorders such as post-traumatic stress disorder.

Public health relevance
PROJECT NARRATIVE The brain’s ability to learn and memorize is essential for everyday life, but a malfunction during the memory process can lead to amnesia or pathological memories such as post-traumatic stress disorder. The main goal of the current proposal is to investigate slow-wave oscillation and associated neural activity dynamics underlying memory consolidation. Results from this proposed study will provide a new mechanistic understanding of sleep associated memory processes and shed light on how dysfunction in these processes leads to pathological states and disorders.